Interdisciplinary Biomedical Research Training Program

7. Project Summary
There continues to be a documented dire national need for veterinary specialists trained
in biomedical research. Furthermore, veterinary researchers play a key role in
multidisciplinary and interdisciplinary research activities since they naturally bridge basic
and clinical research. To address this training need, faculty in the North Carolina State
University College of Veterinary Medicine (CVM) established the Interdisciplinary
Biomedical Research Training Program (IBRTP) for veterinary students in 2009 with funds
committed to the program from the College of Veterinary Medicine and the T35 was first
funded in 2010. The objective of this training program is to provide interdisciplinary
biomedical research experience specifically targeted to veterinary students with a strong
interest in a research career. The training program also serves as a bridge to foster new
interdisciplinary research collaborations amongst faculty members. Trainees complete a
3-month research experience in the laboratories of faculty members drawn from nine
disciplines. Trainees are mentored by two faculty members from different disciplines to
create and execute an interdisciplinary project. The 36 training faculty members
participating in this program are well funded and have a strong training track record. The
disciplines selected are areas of strength at NC State; cellular and molecular biology,
neurosciences, genetics and genomics, infectious diseases, disease modeling and
epidemiology, regenerative medicine, gastrointestinal physiology, computational biology,
and pharmacology and toxicology. Research projects emphasize integration of disciplines
to create a novel approach to a biomedical research problem. Projects combining clinical
and basic science disciplines are given priority. Trainees will be veterinary students in their
first or second year who are building on prior research experience. A total of 119 NIH
funded trainees have completed the program. We request in this renewal application that
the number of NIH funded training slots be maintained at 10 per year. Program
requirements include: 1) a weekly Principles of Comparative Biomedical Sciences seminar
series; 2) a seminar series on the Principles of Interdisciplinary Collaboration; 3) Scientific
Communication workshop; 4) training in responsible conduct of research, research rigor,
and data science and statistics; and 5) participation in the Veterinary Scholars Symposium
and the CVM Research Symposium.

Public health relevance
8. Narrative This Interdisciplinary Biomedical Research training program (IBRTP) addresses two critical national needs in biomedical research. First is the growing need for Veterinarians with training in biomedical research. Second is that more emphasis needs to be placed on translation of basic research advances to the clinical setting and this often requires an interdisciplinary approach.